LEFT VENTRICULAR REMODELING AND NEUROHORMONAL ACTIVATION IN MYOCARDIAL INFARCT

Twenty-four subjects will be studies post Q-wave MI prior to hospital discharge, 6 weeks and 6 months. This study will test the hypothesis that exercise can be detrimental due to excessive myocardial stretch and that this can be reduced by combining either standard exercise or subthreshold exercise regimens with ACE inhibition.